BIOREPOSITORY OF HUMAN INDUCED PLURIPOTENT STEM CELLSFORCARDIOVASCULAR DISEASES (BHIPSC-CVD) - TASK AREA B

This proposal is prepared in response to the NIH/NHLBI request to establish a "Biorepository of Human Induced Pluripotent Stem Cells for Cardiovascular Diseases" (hereafter "Biorepository"). The proposed Stanford Cardiovascular Institute (SCVI) Biorepository will curate and manage an expanded collection of human induced pluripotent stem cell (iPSC) lines and provide investigators with iPSC materials generated using standardized protocols, with the overall objective of promoting the continued adoption and development of iPSC technology in cardiovascular research.

Human iPSCs have revolutionized disease modeling, drug screening, and therapeutic research. However, it is also recognized that the need for specialized technical expertise and the associated cost have largely prevented individual research laboratories from adopting iPSC models in their inquiries, particularly in studies requiring multiple cell lines. To address this bottleneck, the proposed Biorepository will maintain our existing collection of iPSC lines and further expand the collection of iPSCs by recruiting 1,000 healthy, hypertrophic cardiomyopathy (HCM), dilated cardiomyopathy (DCM) donors of both sexes and diverse racial/ethnic backgrounds (African Americans, Asians, Hispanics, and Whites). We will continue to provide cell materials to investigators at minimal shipping costs as well as open access to de- identified characterization data on our public website.

In the past five years, our team has delivered over 2,500 vials of iPSCs and iPSC-derived cardiomyocytes (iPSC-CMs) to over 250 investigators in the cardiovascular research community. The proposed SCVI Biorepository will inherit established organizational assets and facilities of the present SCVI iPSC Biobank, which was established in 2014 under a 5-year NHLBI support through the R24 mechanism (R24 HL117756; 4/15/2014 - 3/31/2020; no-cost extension). The SCVI Biorepository is located on the Stanford campus and occupies 2,500 sq. ft of modern facilities that are wholly dedicated to the proposed biobanking service and sandboxed from academic research activities. Stanford offers a supportive institutional environment and world-class infrastructure, including the REDCap (Research Electronic Data Capture) and STRIDE (Stanford Translational Research Integrated Database Environment) clinical informatics data management systems, campus-wide high-speed secure networks, and secure internal servers for resource management.

We have assembled a team of expert investigators and skilled staff with suitable experience and training from our SCVI Biobank. Our leadership team, internal scientific advisory board, and three core staff teams (Administrative, Technical, and Recruitment teams) stand ready to work with NIH/NHLBI and external advisors to tackle operational and scientific needs of the Biorepository. Particular focus will be given to resource management to maintain existing resources and anticipate future expansion. We possess ample experience to handle service requests and administer material transfer, sample shipment, and logistics. In the proposed SCVI Biorepository, we will work with NIH to further codify our expertise by Authoring a Manual of Operations (MOP) and creating an automated trackable request system, which will us meet ongoing challenges of scaling up iPSC delivery to promote future advances.